Genetic Control of Development

DESCRIPTION (provided by applicant): It is clear that growth and sporulation are inexorably intertwined in the most fundamental of cellular functions including chromosome replication and division but the mechanisms that join these processes are poorly, if at all, understood. This research program investigates regulatory connections between the coordination of cell growth and division and the basic mechanisms by which proteins evolve molecular recognition. This proposal investigates two-component signaling at several levels. A vital system, YycFG, required for homeostatic maintenance of cell wall and membrane components essential for growth is shown to be physically associated with the division mechanism and to receive and possibly coordinate signaling between division and cell wall synthesis. Protein:protein association in heterologous multiprotein complexes is one means for sharing information between processes. How proteins know who to assemble with is determined by interaction surface residues and in this proposal we investigate how covariance of amino acid residues between interacting proteins and therefore their interacting surfaces may be identified by analyses of large sets of proteins deduced from genomic sequence databases. Despite the considerable evidence for the interweaving of regulatory controls for growth and sporulation, there is very little known of signals or mechanisms that decide between the two outcomes for cell division, growth or sporulation. New investigations are proposed in understanding sensor kinase regulation and to delve deeper into the regulatory connections with growth. The significance of this research is not limited to understanding the phosphorelay and sporulation in a corner of the bacterial world but has regulatory implications for signal transduction in eukaryotes and plants.